GENEINDEX-A TOOL FOR ANALYZING N-TUPES ACROSS WHOLE GENOMES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a request for a renewal of TG DAC TG-MCB070097T. I would like to request an extension of 90 days to complete the work (fall was a busy time...)